CYTOTOXIC LYMPHOCYTE SERINE PROTEASES (GRANZYMES): MODELS OF SPECIFICITIES

Cytotoxic T and natural killer lymphocytes have unique granules that are released to kill other cells "targeted" for death. The granules contain a pore-forming protein, perforin, and a set of serine proteases (granzymes) that are essential for pore formation. Our hypothesis is that one or more of these granzymes cleaves perforin to activate pore formation. There are over eleven different granzyme genes, including five in the rat which I have already cloned. The unfractionated granzymes in granule extracts have at least five different primary cleavage specificities. The perforin gene has also been cloned and sequenced. The low native abundance of granzymes and perforin makes it difficult to purify the proteins to examine the cleavage specificity. I will be modeling the granzymes based on other serine protease crystal structures to visualize their structures and to predict their substrate specificities. The predictions will be compared with the synthetic substrate activities of recombinant granzymes (that I am now expressing from the rat genes) and with their activity vs. native perforin. Our initial studies predict that one of the granzyme genes encode a chymase. Also, I have found that chymase activity co-purifies with perforin and is essential for its lytic activity. When I get the recombinant P7 granzyme, I will see if it has the predicted chymase activity and if it cleaves perforin. Since additional granzymes genes also encode other chymase, I will next visualize the extended P7 substrate binding sites and determine if they match actual cleavage sites observed when native perforin is cleaved during lytic activity. I have used the Computer Graphics Laboratory to generate models of granzyme serine proteases to predict their primary substrate specificity.